Dissecting neuroinflammatory mechanisms in a model of progressive TDP-43 pathology

Project Summary/Abstract
Neuroinflammation, where immune cell overactivation can lead to catastrophic destruction of otherwise
healthy neuronal tissue, is a critical pathological feature of both Alzheimer’s Disease (AD) and Amyotrophic
Lateral Sclerosis (ALS). Dissecting the pathways leading to pathological neuroinflammation and defining precise
immunomodulatory targets has the potential to greatly enhance therapeutic options for those suffering from
neurodegenerative diseases. 97% of ALS patients and 57% of AD patients present with dysregulation of the
RNA-binding protein TDP-43 in neurons, leading to disrupted RNA splicing of a variety of critical genes. Our
bioinformatic analysis has identified 23 genes commonly dysregulated by TDP-43 pathology in multiple
independent human studies; among these is STMN2, which we have characterized as a regulator of NMJ
function and stability, and ATP8A2, which has never been studied in the context of AD or ALS, yet is an extremely
attractive target for studying neuroinflammation. ATP8A2 is a phosphatidylserine (PS) flippase that regulates PS
exposure onto the extracellular leaflet of the plasma membrane, where it acts as the cellular “eat me” signal for
immune cell activation and phagocytosis. Aberrantly exposed PS can occur via flippase dysfunction, which is
sufficient to cause neuronal phagocytosis by neuroimmune cells. Humans with ATP8A2 mutations have severe
neurological dysfunction and ATP8A2 mutant mice develop axon degeneration, implicating ATP8A2 as a primary
regulator of neuroinflammation and axon loss, downstream of impaired TDP-43. Excitingly, we have found that
ATP8A2/STMN2 double heterozygote mice display a progressive decrease in motor strength that is significantly
different from either single heterozygote, demonstrating the utility of this model for investigating TDP-43
pathology. This project will determine the genetic and cellular regulators of PS exposure and neuroimmune cell
activation, and test the degree to which ATP8A2 deficiency exacerbates the neurodegenerative phenotypes (e.g.
STMN2-mediated NMJ defects) observed in TDP-43 pathology. If successful, this project will characterize the
fundamental mechanisms of neuron/immune cell interactions, and define potential therapeutic targets against
neuroinflammation in AD or ALS.
This project will occur at Washington University in St. Louis, a premier institute for biomedical research,
under the guidance of Aaron DiAntonio, who has become a leader in the field of axon degeneration over the past
two decades. The DiAntonio Lab’s record of success accentuates the resources and equipment available to
perform outstanding science, including two state-of-the-art tissue culture rooms, multiple automated cell imagers
and confocal microscopes, and access to a world-class mouse facility. Additionally, the extraordinary
neuroscience and immunology communities at Washington University provide excellent opportunities to facilitate
the growth and transition from trainee to independent investigator, which will occur through the classes, lectures,
journal clubs, retreats, and symposia offered by the institution.

Public health relevance
Project Narrative 97% of ALS patients and 57% of Alzheimer’s Disease patients present with dysregulation of the protein TDP-43, causing disruption of a variety of critical genes, leading to neurodegenerative disease. Neuroinflammation, an understudied facet of ALS and Alzheimer’s Disease, occurs when overactive immune cells cause catastrophic damage to otherwise healthy neuronal tissue. Using neuron/immune cell culture and a mouse model of TDP-43 pathology that exhibits a progressive neurodegenerative phenotype, this project aims to understand the genetic and molecular regulators of neuroinflammation and characterize potential therapeutic targets for ALS and Alzheimer’s Disease.